ALIVE: Development and feasibility of a psychosocial stress intervention for autistic adults

This is a K23 award application for Dr. Laura Graham Holmes, a clinical psychologist with expertise in autism, to independently conduct research to develop psychosocial interventions that will improve mental health and quality of life for autistic adults. The K23 will provide her with the support necessary to acquire critical skills in three key career development areas: 1) community-engaged intervention development; 2) clinical trial design and evaluation of implementation; 3) developing ethical data and safety monitoring protocols for populations at heightened risk for suicide. To achieve her goals, Dr. Graham Holmes has assembled an interdisciplinary mentoring team comprised of Dr. Susan White (Co-Primary Mentor), a recognized leader in psychosocial intervention development in autism, Dr. Sarit Golub (Co-Primary Mentor), a leading expert in clinical trials and implementation science, and Dr. Carla Mazefsky (Co-Mentor), a pioneer in research on emotion dysregulation and suicide in autism. Complementing these experts, Dr. Graham Holmes also has a 5-member advisory committee to support her proposed development of a psychosocial intervention for autistic adults.
Current evidence demonstrates that autistic people are at increased risk for co-occurring mental health conditions including depression, anxiety, and suicide attempts compared to others. Autistic adults also report more unmet mental health care needs. Dr. Graham Holmes’ objective is to address the lack of available evidence-based psychosocial interventions for autistic adults facing stress due to certain personal and social factors. Her research will result in preliminary data to support a clinical trial to test a novel community-based stress management intervention for autistic people. The intervention will adapt evidence-based principles for addressing stress management and social engagement among non-autistic people experiencing stress using a co-designed, co-facilitated, online group psychoeducation intervention approach. She proposes the following Specific Aims: Aim 1: Gather formative qualitative data from autistic people and professionals with relevant experience to inform the development of the ALIVE Intervention; Aim 2: Pilot test and refine the intervention content, delivery, and efficacy and implementation measures via a randomized controlled trial in preparation for a Hybrid Type 1 (efficacy + implementation) clinical trial.
The proposed research is significant because it will result in an accessible, scalable intervention for a population with unmet mental health care needs. The proposed research is innovative because it uses an evidence-based approach designed to address stress that will be adapted via a community-engaged process for autistic adults.

Public health relevance
Autistic adults are at high risk for co-occurring mental health conditions including depression, anxiety, and suicide attempts and require a psychosocial intervention tailored for their unique needs. This research involves developing and piloting a novel community-based stress management intervention for autistic adults. The emphasis on preparing for future adaptive interventions and on safe, ethical research with a population at heightened risk for suicide will make significant contributions to the autism research field and will promote the ultimate goal of improved psychosocial functioning and mental health in the autistic community.